American Society for Intercellular Communication (ASIC)

Abstract: The current R13 proposal is from the American Society for Intercellular Communication (ASIC)
which was created in January 2021 with a goal of creating a home for research encompassing emerging
mediators and pathways of intercellular communication (IC) beyond the scope of the existing societies.
Organizers have focused on regular yearly meetings with interest in extracellular vesicles, Biomolecular
Condensates and RNA (EV/EP/ExRNA) and other complex pathways of molecular exchange. The 2nd
meeting (October 13th- 15th, 2022) had 149 participants, 95% attended in-person. We started with a “Pre-
meeting” session with talks from NCATS, NIDDK, NIC, and NHLBI program officers and their funded PIs.
Nobel Laurette Dr. Thomas Sudhof was our keynote speaker for the opening Thursday night session.
The 2023 current meeting will provide an intellectual home for young scientists who are interested in basic
science and bench to bedside related EV and non-EV type of research. The location of the meeting
(Bolger Center; Potomac, MD) provides a platform that allows direct communication between PIs and
program officers from government agencies with interest in EV research including NIH, NIST, FDA, and
NSF. The meeting is unique and novel in many ways including topics covering a broad range of IC
processes far beyond the focus of existing societies that have largely been dominated by exosome-
related research. Also, the cost of the meeting is low, so that students, postdocs, and PIs can afford to
attend; there is a proposed pre-meeting workshop which allows direct contact with POs from various
NIH funding agencies; the meeting will increase the DEI pool with emphasis on women and minority
trainees; inclusion of a mentoring session (speed dating) will promote a cross talk for creating mentor-
mentee pairs, that will help young trainees; and a grant writing workshop is unique in that it discusses
how to write various types of EV and non-EV grants (i.e., K, R, T, P and U series for NIH) for early and
seasoned investigators. Our Aims for the 2023 meeting include: Bring together investigators from diverse
basic science and clinical fields to discuss and advance understanding of the multifactorial impact of
EV/EP/ExRNA in diagnostics, treatments, and a basic understanding of the biogenesis of normal vs.
diseases states (AIM 1); Engage young new investigators (including women and minorities) in the field
of EV/EP/ExRNA and their advancement in becoming independent successful colleagues by helping
them write better grants (AIM 2); and Bring together interested parties to discuss relevant key significant
topics regarding IC, and disseminate information presented at the conference to the scientific community-
at-large as well as to health care providers and the general public. This would also help in finding qualified
reviewers for NIH study sections (AIM 3).

Public health relevance
Project Narrative: The American Society for Intercellular Communication (ASIC) meeting has a goal of bringing top researchers focusing on emerging mediators and pathways of intercellular communication (IC) beyond the scope of the existing societies. The focus is mainly on extracellular vesicles, particles, biomolecular condensates, and RNA (EV/EP/ExRNA) and other complex pathways of molecular exchange. The ASIC meeting will promote the inclusion of Under Represented Minorities (URM) and reduce the impact of gender or other bias, by changing the very culture of science using evidence-based approaches to advance diversity and eliminate barriers to recruitment, to foster successful career transitions, and to improve representation in academic leadership positions.